Dementia Friendly in the Context of Hospitalization: A Qualitative Descriptive Study on Family Caregiver Inclusion

Project Summary/Abstract
The purpose of this individual National Research Service Award (NRSA) is to provide research training that will
enable the applicant to become an independent researcher focusing on interventions for improving outcomes
and experiences of hospitalized persons living with dementia (PLwD) and their family caregivers. This NRSA
will ensure that the applicant achieves competence in establishing an understanding of the care of PLwD and
their family caregivers, develops foundational skills to commence a program of research with this vulnerable
population, and gains professional development skills to advance in a rigorous academic setting. This training
will occur in a resource rich environment with support from a world-renowned advising team ideally suited to
the applicant's topic and training plan. Informed by her work as an acute care nurse and a clinical nurse
specialist, the applicant has first-hand knowledge of the importance of improving the outcomes and
experiences of hospitalization for PLwD and their family caregivers.
PLwD experience adverse outcomes resulting from hospitalization at greater rates than older adults without
dementia. The term “dementia friendly” in the context of hospitalization, is a developing concept that describes
initiatives aimed at addressing these adverse events and improving the experience of hospitalization for PLwD
and their family caregivers. The inclusion of family caregivers during hospitalization is a tenet of the dementia
friendly concept and is considered a best practice in dementia care. Key stakeholder perspectives about
dementia friendly practices, as well as strategies for implementing the inclusion of family caregivers, are
lacking, especially in the United States. This study proposes to fill this gap in knowledge through the following
aims: Using qualitative, semi-structured interviews, the perspectives of approximately 16 hospital dementia
care triads, including hospital nurses who care for PLwD, hospitalized PLwD, and their family caregivers, will
be gathered and analyzed to 1) describe the concept of dementia friendly in the context of hospitalization, 2)
describe how family caregivers of PLwD are currently and could be included during hospitalization, and 3)
identify facilitators and barriers to the implementation of dementia friendly practices, including the effective
inclusion of family caregivers of PLwD during hospitalization. The study will use a descriptive, qualitative
approach, guided by the Consolidated Framework for Implementation Research, to describe the triangulated
perspectives of these affected individuals within and across the various role types. This study has the potential
to provide new knowledge that will 1) advance the concept of dementia friendly in the context of hospitalization
and 2) identify facilitators and barriers to the implementation of dementia friendly practices and the effective
inclusion of family caregivers for PLwD during hospitalization.

Public health relevance
Project Narrative This proposal will describe the perspectives of hospital dementia care triads comprised of nurses, hospitalized persons living with dementia, and their family caregivers regarding the concept of dementia friendly in the context of hospitalization and the effective inclusion of family caregivers during hospitalization. Guided by an implementation science framework, this qualitative approach supports the elicitation of perspectives of affected individuals. This will lay the foundation for the development and testing of interventions designed to improve the experience of hospitalization for persons living with dementia and their family caregivers.